Mayo Clinic Center for Clinical and Translational Science (CCaTS)

Contact PD/PI: Lucchinetti, Claudia F.
OVERALL: Project Summary/Abstract
Mayo Clinic is one of the largest not‐for‐profit, academic health systems, top-ranked for quality more often than
any other health care organization. It has integrated operations in 5 U.S. states, and more than 1 million people
came to Mayo Clinic for care last year. Clinical and translational science (CTS) is a fundamental and highly
valued element of Mayo Clinic; indeed, all research at Mayo Clinic is directed towards translation of scientific
knowledge to improve patient care, with almost 60% of our NIH funding base classified as clinical research or
trials. In recognition of the importance of continued advances in CTS to the Mayo Clinic mission, our
institutional leadership has entrusted the Mayo Clinic Center for Clinical and Translational Sciences (CCaTS)
to be the engine of translational innovation and the institutional advocate for CTS and translational research.
CCaTS has served as a CTS innovation incubator for numerous efforts that were created with CCaTS funding
and are now supported by the institution. The overall vision of CCaTS is to enable high-quality, team-based
multidisciplinary research that accelerates clinical trial innovation, facilitates digital health transformation, and
partners with our stakeholders and communities to improve patient care and health for all people. Our team-
based culture has been described as one of “boundarylessness,” wherein organizational barriers are removed
to enable talent, innovation, and knowledge to converge where needed. In this context and that of our
longstanding commitment to patient-focused research, we are uniquely positioned to accomplish the following
Specific Aims. In Aim 1, we will simplify and accelerate the work of translation to improve health for all by
advancing clinical trial innovations and digital health transformations, streamlining methods and processes,
and developing novel informatics solutions that increase efficiency and drive implementation of discoveries that
improve health and promote health equity. In Aim 2, we will enhance our education programs through the
expanded reach of competency-based, learner-focused solutions, training a diverse, inclusive, multidisciplinary
CTS workforce to be prepared to address the urgent health care needs of all communities in a rapidly changing
environment. In Aim 3, we will engage local community members and patients to be active partners in
translational teams, expanding research capabilities of underserved communities, including rural populations.
Our goal is to improve health and reduce health inequities by helping these communities realize the benefits of
CTS. In Aim 4, we will expand national and regional partnerships and strengthen collaborative CTS networks
in all aspects of CTS and education, focusing on sharing innovative approaches and prioritizing diversity,
equity, and inclusion, with the goal of improving human health and advancing health equity. In summary,
sustained investment in CCaTS will enable us to continue to meet ongoing and emergent challenges in health
care for all, as exemplified by our response to support communities through the COVID-19 crisis.
Project Summary/Abstract Page 289
Contact PD/PI: Lucchinetti, Claudia F.

Public health relevance
PROJECT NARRATIVE The Mayo Clinic Center for Clinical and Translational Sciences (CCaTS) accelerates innovations in clinical research and partners with our stakeholders and communities to improve patient care and human health for all people. It supports scientists who bring new discoveries to clinical practice, trains a diverse multidisciplinary workforce prepared to address the urgent health care needs of all communities in a rapidly changing environment and works closely with other research centers across the country to share innovative approaches. Project Narrative Page 290